Neurobiology of Paternal Care

Project Summary / Abstract
Child health stands to benefit greatly from nurturing fathers or be harmed by paternal abuse and neglect.
However, little is known about the neural basis of paternal behavior in any species, and there has been no
thorough mechanistic account for why some fathers are nurturing while others are abusive or neglectful.
Moreover, there is little information on how these phenotypes may be shaped by environmental experience. In
the proposed research, I will use a novel biparental rodent model species, the African striped mice (ASM), to
elucidate the neural and social-experiential mechanisms governing differences in paternal care. Male ASM
readily exhibit pup care both before and after sexual experience and display natural variation in paternal care.
ASM paternal phenotypes are also influenced by peri-adolescent social experience. Thus, using ASM, it is
uniquely possible and convenient to observe both naturally occurring individual differences and experientially
induced phenotypes in a single rodent species. In order to elucidate the neurobiological mechanisms subserving
individual differences in paternal care, I will use a combination of behavioral, circuit activity mapping,
pharmacogenetic, and molecular techniques. In Aim 1, I will define a “paternal brain network” of brain-wide pup-
induced neural activity using whole-brain imaging and computational analysis. I will then test the functional
relevance of neural activity in key regions for paternal care behavior by chemogenetic manipulation (i.e.,
DREADDs). This aim will determine whether activity in specific brain regions or patterns of coordinated brain
activation subserve natural variation in paternal behavior– from caring to abusive. In Aim 2 I will characterize the
transcriptional basis of variation in paternal care using single-nucleus RNA sequencing in one key brain region.
This aim will distinguish whether activity in specific cell types drive natural variation in paternal care, and whether
specific genes or biological pathways are linked with paternal vs infanticidal behavior. Taken together, the
proposed studies will enable me to gain training in a number of cutting-edge techniques while substantially
advancing the collective understanding of the neural activity and molecular basis of variation in paternal care,
with future applications for improving caregiving and offspring outcomes.

Public health relevance
Project Narrative Caring fathers can directly support child physical health and behavioral development while abusive and neglectful fathers can prove harmful. It remains largely unknown at the neural level why some adult males demonstrate care while others demonstrate abuse or neglect, and there is little information on how these variable paternal phenotypes may be shaped by social and environmental experience in earlier development. The proposed research will use a biparental rodent model species to elucidate the neural activity and molecular mechanisms associated with natural variation in paternal care.